Modeling Retinoblastoma Initiation Using 3D-Retinal Organoids

PROJECT SUMMARY
Several landmark discoveries in cancer genetics have come from studies on a rare childhood cancer of the
developing retina called retinoblastoma. In parallel, advances in preclinical testing and clinical research has led
to improvements in outcome for children with this devastating disease. Despite these advances, there are still
fundamental questions in the retinoblastoma field that remain unanswered. Are retinal cells fully transformed
once they sustain biallelic inactivation of the RB1 gene or is retinoblastoma tumorigenesis a multistage
process? Why do some family members with the same germline RB1 mutation have bilateral multifocal
retinoblastoma at a young age while others have no evidence of disease? Can treatment induce a process of
tumor cell clonal evolution and selection that leads to tumor progression and enucleation? These questions
have been impossible to answer because retinoblastomas are not biopsied and enucleation is only performed
for advanced stage eyes. In order to overcome this barrier in the field, we have developed the first
spontaneous human retinoblastoma tumor model using 3D retinal organoids produced from patients with
germline RB1 mutations. I have assembled a multidisciplinary team with expertise in computational and stem
cell biology, oncology, pathology, epidemiology and biostatistics to use this innovative new model of
retinoblastoma to answer fundamental questions in 3 specific aims. We will determine if retinoblastoma
progresses through a multistep process (Aim 1), if molecular, cellular or genetic factors contributes to
differences in penetrance and expressivity (Aim 2) and if there is clonal selection with treatment (Aim 3). I have
a proven record in retinoblastoma genetics and of moving basic science discoveries into clinical trials. This
proposal will impact patients with retinoblastoma through preclinical testing of a novel maintenance therapy
(Aim 3) to prevent new tumors from forming in the peripheral retina in the first few months after completion of
chemotherapy. It may also help to identify a subset of retinoblastoma survivors with germline RB1 mutations
that have an ultra-high risk of developing a 2nd malignancy and require more extensive cancer screening (Aim
2). No other center has the team, resources, expertise, or tools available to perform the studies presented
here and efficiently move the most promising findings directly into a clinical trial.

Public health relevance
PROJECT NARRATIVE (Relevance Statement): We have developed the first spontaneous human retinoblastoma tumor model by using iPSCs from patients with germline RB1 mutations. Using this model combined with our extensive collection of orthotopic patient- derived xenografts we will determine if retinoblastoma tumorigenesis is a multistep process and study the clonal evolution and selection of tumor cells during treatment.